CORE GRANT FOR VISION RESEARCH

The Wilmer Core Grant has productively supported over thirty National Eye Institute-funded principal investigators with the following four modules: Computer Electron Microscopy Machine Shop Biostatistical/Clinical Vision Research Center Each of the Core units will provide important research enhancement to a moderate or maximum usage level for at least eight National Eye Institute-funded researchers, with facilitation of collaborative studies. We will encourage some sharing of Core Grant resources and services with non-NEI funded collaborators and with investigators new to vision research, as time permits.